Identify the target proteins of one ADC-specific and two SCC-specific pfeRNAs and investigate the mechanisms underlying the pfeRNA-protein interaction.

Project Summary:
Lung cancer continues to be a significant health burden in the U.S. Thus, a functional understanding of the
critical molecules during NSCLC oncogenesis will enhance our knowledge of its malignant transformation, and
allow novel therapeutic strategies.
We have recently identified critical roles of protein function effector sncRNAs (pfeRNAs) in the tumorigenesis
and differentiation of NSCLC, have described their functions in the basic biology of NSCLC, and have
elucidated their structural and functional features. We have identified eight pfeRNAs as promising non-invasive
biomarkers using sncRNAs deep sequencing by analyzing 108 biospecimens, including (i) plasma from healthy
controls, (ii) plasma from patients with Stage I/II NSCLC with matched biopsy-proven NSCLC tissue as well as
histologically normal adjacent lung tissue, and (iii) plasma from patients with both biopsy-proven benign and
malignant lung nodules. We have already validated these biomarkers in 352 clinical biospecimens, including
77 healthy controls, 44 patients with benign disease, and 231 patients with malignant lung nodules. These
eight pfeRNAs were able to: (1) to differentiate patients with or without pulmonary nodules, with a sensitivity
and specificity up to 98.1% and 100%, respectively; (2) to differentiate patients who had malignant versus
benign pulmonary nodules, with a sensitivity and a specificity up to 78% and 78.8%, respectively. Furthermore,
we identified a pfeRNA is ADC-specific and two pfeRNAs are SCC-specific. Besides, we have confirmed
functional analyses of these three pfeRNAs one by one and identified their roles in the primary biological
activities of ADC, SCC, and HBE cells in vitro. In addition, we specified the cellular distribution of these three
pfeRNAs by fluorescence in situ hybridization (FISH) assay. The data strongly suggest that these three
pfeRNAs play critical roles in tumorigenesis and cancer development of NSCLC. Thus, in this project, we will
identify the target proteins of these three pfeRNAs and investigate the mechanisms underlying the interaction
with the target proteins. This project will provide new evidence on NSCLC oncogenesis.

Public health relevance
Project Narrative: Despite the development of novel targeted treatment and immune therapies that have prolonged survival in some patients with non-small cell lung cancer (NSCLC), NSCLC is still the leading cause of cancer-related death in the U.S. We will identify the target proteins of an ADC-specific and two SCC-specific pfeRNAs and decipher the machinimas underlying their interaction, opening a new window of understanding in the sncRNA field and providing new evidence on NSCLC oncogenesis.